Neurovascular protein lifetime in health, aging and Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
In the central nervous system (CNS), blood vessels have specialized functions that are critical for maintenance
of CNS homeostasis. These include the blood-brain barrier (BBB), which tightly controls the access of ions,
molecules, and cells to the CNS, and neurovascular coupling, a process by which blood flow is transiently
increased to regions of elevated neural activity. Further, vascular cells regulate development and function of
neurons and glia, and perivascular spaces serve as conduits for cerebrospinal fluid circulation, which may be
important for waste clearance. These processes rely on the coordinated function of many cell types, including
endothelial cells, pericytes, vascular smooth muscle cells, perivascular fibroblasts, astrocyte endfeet, and
immune cells, which together constitute a neurovascular unit (NVU). Emerging evidence suggests that many
NVU properties are dynamically regulated by physiological cues, including circadian rhythms and neural activity.
This suggests that the CNS vasculature achieves a balance between the stability required to achieve continuous,
highly tuned oxygen and nutrient delivery, and the plasticity required to dynamically modulate function.
Importantly, NVU dysfunction is observed in aging and neurological diseases, including Alzheimer's disease,
and such dysfunction contributes to the associated CNS pathology. A better understanding of the molecular
mechanisms underlying neurovascular stability and plasticity in health, and age- and Alzheimer’s disease-
associated dysfunction, may reveal new molecular targets for treating this dysfunction. This project will address
this knowledge gap by quantifying the lifetimes of neurovascular proteins in health, aging, and Alzheimer’s
disease. Protein lifetime is a fundamental parameter that profoundly influences protein function, and thereby
influences cell and tissue function: long-lived proteins can stabilize cellular structures, but are also susceptible
to accumulated damage; short-lived proteins are amenable to rapid modulation by physiological cues, but have
high energetic burden. Changes to protein lifetimes are potential mechanisms of aging- and disease-associated
cellular dysfunction. Although protein lifetimes have been measured in the CNS, the vast majority of
neurovascular protein lifetimes have not been quantified due to the low vascular fraction in whole brain tissue.
This project will generate a comprehensive atlas of neurovascular protein lifetimes in health, aging, and a
tauopathy-based model of Alzheimer’s disease. Aim 1 will employ stable isotope labeling in mammals (SILAM),
nonenzymatic vessel isolation, and mass spectrometry-based proteomics to quantify protein lifetimes, and
identify changes in aging and Alzheimer’s disease. In Aim 2, single nucleus RNA-seq will be used to define the
cellular and transcriptomic composition of isolated microvessels, and allow inference of cell type(s) of origin of
proteins detected in Aim 1. Together, this work will advance understanding of the molecular bases of
neurovascular function and yield new hypotheses for molecular mechanisms underlying age- and Alzheimer’s
disease-associated neurovascular dysfunction.

Public health relevance
PROJECT NARRATIVE In the central nervous system (CNS), blood vessels have specialized properties that maintain CNS health and are compromised in aging and disease, but we do not fully understand the underlying molecular mechanisms. In this project, we quantify protein lifetimes (how long each protein exists before being degraded and replaced) in CNS blood vessels and determine how these are altered in aging and a mouse model of Alzheimer’s disease. These data will provide fundamental knowledge about the molecules that establish CNS vessel function and may yield new strategies to treat dysfunction.